Identifying and Targeting 3D Regulatory Nodes that Maintain Glioblastoma Programs

PROJECT SUMMARY
Glioblastoma (GBM) is a highly aggressive and incurable brain tumor. The inter-patient and intra-tumoral
heterogeneity of GBM, resulting from genetic alterations and epigenetic plasticity, poses a major challenge in its
treatment. GBM IDH-wt tumors are composed by different proportions of transcriptionally defined cell states,
which although resemble neurodevelopmental cell types, are highly plastic and interconvertible -rather than
hierarchic- as we and others have shown. This suggests the presence of a core regulatory logic that enables
toggling among different transcriptional states, endowing GBM tumors with increased phenotypic plasticity and
fitness. Here, we aim to unravel core regulatory modules that are critical for GBM programs with a particular
focus on enhancers, which together with transcription factors govern cell-state specific programs. Enhancer
dysregulation by genetic variants and epigenetic mechanisms is increasingly appreciated as a key process in
oncogenic transformation and drug resistance. However, dissecting and modulating enhancer function remains
very challenging due to the large number of putative enhancers and the complex ways they control their target
genes in the context of the three-dimensional (3D) genome. By constructing 3D enhancer-promoter interaction
networks in four patient-derived glioma stem-like cells (GSCs) and normal neuronal stem cells -as controls- we
have identified a subset of GSC-specific hyperconnected enhancers, which we coin "3D regulatory hubs”. 3D
hubs harbor genes with robust and coordinated transcriptional levels that enrich for oncogenic pathways and are
associated with worse patient outcomes. Importantly, epigenetic perturbation of a highly-recurrent enhancer hub
in GSCs resulted in concordant donwregulation of multiple hub-connected genes, leading into significant shifts
in the transcriptional states and altered clonogenic and proliferation capacities. Building on this foundational
work, we propose that de novo 3D regulatory hubs (established by genetic or epigenetic mechanisms)
lie in the core of GBM networks, where they connect and control multiple target genes, resulting in non-
linear effects on the transcriptional program and oncogenic behavior. To address this hypothesis, our
interdisciplinary team will combine advanced chromatin topology assays, computational modeling and network
analysis with state-of-the-art epigenetic engineering and proteomics tools as well as powerful ex vivo and in vivo
functional assays. Specifically, we will pursue the following aims: (i) characterizing the inter-patient and intra-
tumoral heterogeneity of 3D regulatory networks and identifying conserved structures across patients and states,
(ii) predicting and targeting candidate central hubs and interrogating the molecular and functional consequences
and (iii) uncovering critical players of hub organization and unique vulnerabilities. The findings will provide
insights into enhancer-based reprogramming of cancer fate, opening new avenues for therapeutic targeting of
GBM and establishing a paradigm for identifying and prioritizing key enhancers and regulatory factors in
oncogenic programs.
1

Public health relevance
NARRATIVE Glioblastoma (GBM) is a deadly and incurable brain tumor, characterized by high inter-patient heterogeneity and intra-tumoral plasticity, which pose significant challenges in developing effective therapies. Here, we aim to uncover and target central regulatory nodes that govern the GBM programs by focusing on essential non-coding DNA elements, known as enhancers. By building networks of enhancer-gene communication in the context of three-dimesional nucleus, we aim to (i) identify common central nodes across patients and cellular states, (ii) dissect their significance in GBM programs and tumorigenic properties and (iii) expose unique vulnerabilities for future targeted therapies.